Program ARISE2: African mental health Researchers Inspired and Equipped

ARISE PROJECT SUMMARY
Program ARISE (African mental health Researchers InSpired and Equipped) responds to PAR
18-901, and is led by the Alan J. Flisher Centre for Public Mental Health at the University of
Cape Town in collaboration with the Department of Psychology at Stellenbosch University.
This application builds on the findings and work conducted during a D71 planning grant .The
aim of the project is to strengthen and extend the postgraduate pipeline in African public
mental health to build capacity for non-communicable disease research across the lifespan,
building on the extensive capacity-building experience of CPMH and our African network. The
objectives of the ARISE program are:
1. To deliver and evaluate a distance postgraduate diploma in public mental health in Africa.
2. To train Masters and PhD students to conduct public mental health research relevant to
their setting, with a focus on the integration of mental healthcare into routine care for NCDs
and infectious diseases, and into community responses to public health threats, such as
the COVID-19 pandemic.
3. To strengthen distance learning, teaching and mentoring skills, and postgraduate student
supervision teamwork and capacity within a regional African network of institutions.
4. To implement and evaluate short courses in implementation and policy research for
policymakers, NGOs and academics from diverse disciplines.
On completion of the grant, we will have a well-functioning distance learning PGDip
platform and program attracting applications from self-funded candidates in addition to those
funded through other mechanisms. We expect to have trained 30 PGDip, 4 Masters and 2
PhD trainees, and at least 8 PGDip graduates would have enrolled for a Masters degree. We
anticipate that the Masters and PhD graduates will continue to be involved in public mental
health research, and will be mentoring and supervising postgraduate trainees. We will have
trained 20 faculty members across our regional network in remote teaching and postgraduate
student supervision and we expect that the early career faculty members will be supervising
at least one postgraduate student each as a primary supervisor. We would have trained 40
policymakers, NGO staff members and academics in implementation, health services and
policy research, and expect that at least 75% would have used their skills/knowledge in their
work within a year of completing the course.

Public health relevance
ARISE NARRATIVE Mental disorders make an increasingly significant contribution to the burden of disease in African low- and middle-income countries, also increasing risk for a range of other health conditions and injuries, yet health systems are poorly resourced to address the problem. Although investment in mental health research capacity building in Africa has increased in recent years, disparities in these areas remain evident particularly in comparison to the substantial funding underpinning research and research training for infectious and other non- communicable diseases in the region. Thus, there is a need for mental health research capacity building in Africa, led by African public mental health researchers, to drive local research priorities and retain precious human resources on the continent.